Project 1: Personalized Adjuvant Immunotherapy for High-risk Colorectal Cancer.

PROJECT 1: Summary/Abstract
Identification of tumor-associated mutated target antigens in individual cancer patients can facilitate a novel
and potentially effective treatment approach in which an immune response against multiple relevant tumor
antigens can be generated using a personalized vaccination approach. While identification of mutated peptide
epitope targets in individual patients remains a daunting technical challenge, recent advances in next
generation genetic sequencing has provided a strong foundation on which to build these efforts. This
approach holds the promise of a more personalized and effective method of activating anti-tumor immunity,
without the toxicities associated with many alternate approaches. However, many fundamental questions
remain regarding choice of optimal tumor antigens and immunostimulatory adjuvants to use for generating
optimal antitumor immunity in cancer patients through vaccination.
The specific objective of this proposal is to generate an effective, personalized vaccine approach for treatment
of metastatic colorectal cancer (CRC) patients. We will test the hypothesis that a vaccination strategy targeting
multiple mutated CRC tumor antigens along with specific combinations of immune adjuvants will be capable of
preventing recurrence of minimal residual disease in post-hepatectomy CRC patients. Our Preliminary
Data shows that the proposed personalized vaccination strategy is feasible, as several CRC patients have now
undergone vaccination in a current clinical trial. In addition, our pre-clinical mouse models have clearly shown
that Toll-like receptor ligands, anti-CD40, and checkpoint blockade can be highly effective combinations of
adjuvants in vivo. However, it is critical to understand the optimal combination of agents to use for vaccination
in order to translate these findings into more effective vaccine strategies for our CRC patients. We thus plan to
focus our efforts on the following Specific Aims:
Aim 1: Design and immunize 20 post-hepatectomy metastatic CRC patients with personalized, neoantigen peptide vaccines combined with a TLR7 agonist and either anti-PD1 or anti-CD40.
Aim 2: Develop novel combinations of immunization and systemic immunomodulation with improved
efficacy using murine CRC tumor vaccine models.
These studies will provide critical information that will guide the future of cancer vaccine design and allow for
testing of vaccination efficacy in a setting of low volume disease. The approach promises to make a
significant positive impact in a disease setting that shows high likelihood of recurrence and limited treatment
options. Furthermore, these studies have a strong potential to make an impact in many other cancer types.

Public health relevance
PROJECT 1: Narrative Cancer vaccines hold great promise as an immunotherapeutic approach, but there are a number of important barriers to be overcome before they can be employed in routine clinical practice. This project will use both clinical and pre-clinical approaches to improving the efficacy of personalized cancer vaccines for patients with colorectal cancer. If the proposed objectives are successful, the results of this project will also be directly applicable to all other cancers, and will have to potential to benefit many other patients with many different cancer types.